Genomic Intensive Data Science Research, Education and Mentorship

The Genomic Intensive Data Science Research, Education and Mentorship (GIDS-REM) program
at the University of Rochester aims to increase the number of researchers with strong quantitative
skills in the genomics workforce. The focus is on training and retaining individuals with broad
quantitative and analytical skill sets in biomedical fields. The proposal aims to 1) create a new
track in genomics data science in the Goergen Institute for Data Science Master’s program
(GIDS-MS) and recruit scholars into the track; 2) build core competencies in genomics data
science through curricular training, workshops, and research experiences; and 3) retain
GIDS-REM fellows in the genomics workforce through mentoring and cohort building.
The innovative features of this proposal combine with existing strengths in research,
academics, and efforts to ensure rigorous training opportunities at the University of
Rochester. This proposal leverages the framework and resources for the existing GIDS-MS
program and implements a new curriculum that trains students in theoretical and applied aspects
of both data science and genomics. Through a partnership with the David T. Kearns Center, the
recruitment strategies will bring in scholars with a broad skill set as GIDS-REM fellows. The
proposal implements a team mentoring approach that will connect fellows to genomics research
advisors throughout the University of Rochester and its Medical Center and industry. This
proposal applies the University of Rochester’s strengths in cancer genomics at the Wilmot Cancer
Institute and translational genomic research at the Clinical and Translational Science Institute.
Key aspects of the proposal are in its mentor training and strong community-building to
allow GIDS-REM fellows to thrive. These approaches will improve the retention of fellows in
doctoral programs or in industry positions in the field of genomics. The effectiveness of the
program will be assessed using quantitative and qualitative benchmarks, and instruments
to evaluate mentor competency and student self-efficacy. The GIDS-REM program will not
only have a direct impact on the fellows and their career directions, but will have a broad impact
on the genomics community at the University of Rochester and beyond.

Public health relevance
The Genomic Intensive Data Science Research, Education and Mentorship (GIDS-REM) program at the University of Rochester creates a fellowship to train, mentor, and develop research experience in Genomics in data science master’s students. This program will increase the number of researchers with strong quantitative skills in the genomics workforce, broaden and strengthen the larger genomics community.